The macrophage/tuft cell SUCNR1 axis in neonatal intestinal inflammation

RESEARCH PROJECT SUMMARY
RPL: Kathryn Burge, PhD
Project Title: The macrophage/tuft cell SUCNR1 axis in neonatal intestinal inflammation
Necrotizing enterocolitis (NEC) is an inflammatory gastrointestinal disease of the neonatal period with an unclear,
and likely multifactorial, pathogenesis. NEC most often affects preterm, very low birthweight (VLBW, < 1500 g)
infants, and risk factors including dysbiosis, formula feeding, and prematurity have been implicated in NEC
etiology. Our long-term goal is to identify interventions promoting healthy development of the intestine and gut
microbiome during early life. Proinflammatory M1 macrophages infiltrate the preterm intestine during NEC,
accelerating mucosal inflammation. In contrast, intestinal tuft cells, inducers of an anti-inflammatory, type 2
immune response, are depleted during murine ileitis. However, experimental expansion of tuft cells protects
against ileal inflammation. Succinate accumulates in the NEC intestine, binding succinate receptor 1 (SUCNR1)
in both mucosal macrophages and tuft cells. While the former perpetuates mucosal inflammation, the latter
induces a tuft cell-mediated anti-inflammatory response, establishing a potential macrophage/tuft cell SUCNR1
axis in the regulation of mucosal innate immunity. Increased passive diffusion and transepithelial transport of
succinate across a porous preterm intestinal barrier, enhanced hypoxia-induced succinate production within
mucosal macrophages, and inflammation-induced tuft cell loss likely contribute to mucosal accumulation of
succinate and ‘runaway inflammation’ typical of NEC. Our central hypothesis is that the macrophage/tuft cell
SUCNR1 axis is dysregulated during NEC. Our preliminary data suggest tuft cells are depleted during preterm
NEC pathogenesis. This project will test the hypotheses that (Aim 1) inhibition of macrophage SUCNR1 signaling
and expansion of tuft cells and tuft cell-associated SUCNR1 signaling, in mice and preterm enteroid coculture
models, will protect against NEC-like injury and that (Aim 2) preterm NEC will be associated with increased
mucosal M1 macrophage SUCNR1 expression, increased expression of transporters directing epithelial
succinate uptake, and decreased tuft cell numbers and SUCNR1 expression compared with age-matched
controls. The overarching goal of this project is to provide novel cell-type-specific molecular targets for NEC, a
disease subject to little clinical improvement within the past few decades. Successful completion of this project
will enhance our mechanistic understanding of NEC, offering potential treatment targets for improved patient
outcomes in a disease with no effective therapeutics beyond surgical intervention and supportive care, and no
effective prophylactic alternatives to human milk.